Enrichment Program

PROJECT SUMMARY – Enrichment Program
The CCDTR EP improves the prevention and management of diabetes and population health for all by advancing research in diabetes translation, promoting scientific exchange among Chicago-area and national investigators, and enhancing interactions between diabetes researchers and investigators from other fields with relevant expertise. Diabetes translation research encompasses a broad array of research methods from clinical trials to community-based participatory research to dissemination and implementation research to data analytics. Successful diabetes translation research also requires that investigators maintain intellectual relationships with the basic sciences and clinical investigation. In addition, successful translation requires robust interaction with clinicians and public health leaders who guide clinical care and shape policies. The enrichment program enhances all these interactions. The Specific Aims of the CCDTR EP are to: 1) Enhance and enrich the environment for diabetes translation research in Chicagoland through seminars, symposia and workshops for trainees, junior investigators, and senior investigators; 2) Create a Chicagoland network of diabetes translational investigators, and community, health care, and public health leaders who work together to improve diabetes population health. The CCDTR EP uses existing UC and NU research and education infrastructure and complements these institutional strengths with outside resources to highlight innovative approaches to achieve both community and population health. The goals of the EP are achieved through seminars with local and guest speakers, special guest lectureships, the Annual Chicago Diabetes Day, the Annual Research Symposia of the Center for Chronic Disease Policy and Research, the Institute for Public Health and Medicine’s Population Health Forum, and regular workshops in medical decision making, health outcomes, implementation science, epidemiology, health services, and grant writing. The CCDTR EP also closely aligns with NIDDK supported T32 training programs in adult and pediatric endocrinology as well as other training programs relevant to the mission of the center such as NIDDK R25, NCATS K12, AHRQ and NHLBI T32 programs. The major benefit of the CCDTR EP is to provide diabetes researchers, ranging from trainees to senior investigators, as well as partners and stakeholders, with a forum to collaborate, innovate, and disseminate outstanding diabetes translation research. In concert with other CCDTR activities, the EP accelerates the conduct, dissemination, and implementation of translational diabetes research across Chicagoland.

Public health relevance
Jointly led by the University of Chicago and Northwestern University, the Chicago Center for Diabetes Translation Research (CCDTR) provides core resources in Research Design, Data, and Analytics; Community Engagement & Population Health; and Accelerating HEalth by Advancing Diabetes Translation in Community Health Centers (AHEAD-CHC) that catalyze and support innovative and rigorous translational research to advance population health for the prevention and management of diabetes. The CCDTR increases the impact of rigorous diabetes translational research to advance population health in Chicago and the nation by organizing partnerships across academic institutions and stakeholder groups into working groups that include: Aligning Clinician-Patient Decision Making; Community Drivers of Health; Implementation of Diabetes Prevention Interventions; Diabetes Cost Analysis and Economic Modeling; Organization and Financing of Diabetes Care in the Safety Net; Diabetes and Aging. The CCDTR attracts and supports multi-disciplinary investigators who are new to the area of diabetes translational research by providing education, catalytic events, mentoring, support for community and stakeholder engagement, pilot and feasibility seed grants, and access to critical translational research core resources.